Acceptance Enhanced Behavior Therapy for Trichotillomania

DESCRIPTION (provided by applicant): Trichotillomania (TTM) is a chronic impulse-control disorder involving the repetitive pulling and removal of one's hair that results in notable hair loss. A growing body of research has noted the public health significance of the disorder. TTM can result in a variety of debilitating physical, psychosocial, occupational and educational consequences. Empirical support for the efficacy of both pharmacological and nonpharmacological interventions for TTM is extremely limited, and there is growing recognition that traditional behavior therapy alone is likely insufficient. At a scientific meeting jointly sponsored by the National Institutes of Mental Health and the Trichotillomania Learning Center (http://www.nimh.nih.gov/scientificmeetings/trichotillomania.pdf), the paucity of treatment outcome research on TTM was noted and a specific recommendation made for researchers to conduct larger randomized clinical trials to evaluate enhancement to current behavior therapy relative to treatment as usual... To guide the enhancement of behavior therapy procedures, research on the psychopathology of TTM has discovered at least two distinct processes that may underlie the disorder. These include a habitual or automatic process and an emotional/cognitive regulatory or focused process. Preliminary feasibility and pilot studies conducted by the PI suggest that a treatment designed to address both of these processes (Acceptance-Enhanced Behavior Therapy for TTM; AEBT-T) may be an effective intervention for adults with the disorder. The current application proposes to compare a 10 session manualized version of AEBT-T to a manualized psychoeducation and supportive therapy (PST) in adults with TTM. Primary outcome variables will be assessed by blind independent evaluators, using a multi-element assessment battery. The relative efficacy of AEBT-T and PST for alleviating TTM-related distress and impairment will also be assessed, and treatment gains will be monitored over a six month follow-up. The primary aim of this study is to compare the benefits of AEBT-T to PST for reducing TTM severity in 84 children and adults (age 18-65) with TTM over a 12-week (10 session) acute treatment period. A secondary aim of the study is to examine the durability of both treatments in acute-phase treatment responders over a 6-month follow-up interval. In addition, a number of exploratory analyses are proposed to explore potential predictors of treatment response. Trichotillomania (TTM) is a disorder that has negative physical, social, occupational, academic and psychological effects. Despite its profound consequences, there exists no well-supported empirically based intervention to treat those with the disorder. The current study addresses the mission of the NIMH by determining if children and adults with TTM can benefit from behaviorally oriented treatment to decrease pulling severity and related distress.

Public health relevance
Project Narrative Trichotillomania (TTM) is a disorder that has negative physical, social, occupational, academic and psychological effects. Despite its profound consequences, there exists no well-supported empirically based intervention to treat those with the disorder. The current study addresses the mission of the NIMH by determining if children and adults with TTM can benefit from behaviorally oriented treatment to decrease pulling severity and related distress. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS 2.A. Overview Trichotillomania (TTM) is a chronic and debilitating impulse-control disorder involving the repetitive pulling and removal of one's hair that results in notable hair loss. At least two distinct processes may underlie TTM, including a habitual or "automatic" process and an emotional/cognitive regulatory or "focused" process. Building on these findings, we have developed and piloted a treatment that combines traditional elements of behavior therapy designed to disrupt habitual processes with components of a mindfulness/acceptance-based treatment designed to improve dysfunctional emotional/cognitive regulatory processes. This study proposes to compare a 12 week manualized intervention (i.e., Acceptance Enhanced Behavior Therapy for TTM, AEBT-T) to a manualized psychoeducation and supportive therapy (PST) in adults with TTM. Primary outcome variables will be assessed by blinded independent evaluators, using a multi-element assessment battery. 2.B. Primary and Secondary Aims The primary aim of this study is to compare the benefits of AEBT-T to PST for reducing TTM severity in 84 children and adults (ages 18-65) with TTM over a 12-week (10 session) acute treatment period. Specifically, we predict that after 12 weeks of treatment, AEBT-T will be more effective than PST in reducing TTM symptom severity, TTM-related impairment, and distress. The current study also has three secondary aims. First, we will investigate moderators and mediators of treatment response. We predict that (a) pretreatment response inhibition and cognitive inflexibility will moderate response to treatment, (b) changes in a measure of experiential avoidance (AAQ) will mediate the changes in the focused pulling scale of the MIST-A, (c) changes in cognitive flexibility will mediate changes in the automatic pulling scale for the AEBT-T group, and (d) treatment compliance will mediate changes in TTM severity. Second, we will compare the acceptability of AEBT-T to PST. We predict that both interventions will be rated by participants as acceptable treatments for TTM with no difference (< 10% difference on measures of acceptance) between groups at Week 12. Finally, we will examine the durability of both treatments in acute- phase treatment responders over a 6-month follow-up interval. We predict that observed gains in AEBT-T responders at Week 12 will be maintained over the follow-up interval. 2.C. Why this Study Is Important TTM produces impairment in physical, social, psychological and occupational functioning,12 but empirically supported treatment options for those with TTM are seriously limited. Support for pharmacological options is equivocal, and research on nonpharmacological options is scarce.12 Non-pharmacological treatments demonstrating success in small pilot studies have included a core procedural element of behavior therapy called habit reversal training (HRT). Still, there is growing recognition that HRT alone is poorly tested and likely insufficient. At a scientific meeting jointly sponsored by the NIMH and the Trichotillomania Learning Center (TLC) (http://www.nimh.nih.gov/scientificmeetings/trichotillomania.pdf), the paucity of treatment outcome research on TTM was noted and a specific recommendation made for researchers to conduct "larger randomized clinical trials to evaluate enhancement to current behavior therapy relative to treatment as usual..." Not only is research on the treatment of TTM important in its own right, but given its overlapping phenomenological and neurological features with OCD and Tourette's Disorder,13 research in TTM may lead to advances in the study of these and other impulse control disorders. The current study is a single site proposal, and should AEBT-T prove to be more effective than PST, we will use the data to justify a larger multi-site trial capable of not only establishing generalized efficacy, but more completely testing the mechanisms of change that will be explored in the current trial.